Functional Effects of Oxytocin Receptor Post-translational Modifications

ABSTRACT
Oxytocin plays a pivotal role in clinical obstetrics, commonly used for labor induction and augmentation.
However, safe administration of oxytocin is challenging due to its wide therapeutic window, often leading to
decreased uterine response with continuous exposure. Reduction in uterine contractility can lead to emergency
cesarean delivery or contribute to post-partum hemorrhage – the leading cause of global maternal morbidity
and mortality. To mitigate these issues, understanding the function of the oxytocin receptor (OXTR) is
imperative. OXTR is a G-protein coupled receptor that undergoes post-translational modifications (PTMs), that
can influence trafficking, function, and degradation of the receptor. Such PTMs include glycosylation, the
covalent attachment of carbohydrates, and ubiquitination, the covalent attachment of ubiquitin proteins. This
study aims to study the impact of glycosylation and ubiquitination on OXTR function through genetic and
pharmacologic interventions. In Aim 1, I will elucidate the effects of glycosylation on OXTR abundance at the
cell surface, oxytocin-binding, and OXTR signaling function. In Aim 2, I will determine the effects of
ubiquitination on OXTR signaling function and degradation of the receptor. Ultimately, by determining
mechanisms of N-glycosylation and ubiquitination that affect OXTR abundance at the cell surface, this work
will uncover new targets to enhance OXTR response, through its trafficking, to oxytocin. In the long term, this
work may lead to development of new strategies to decrease the rates of labor complications and maternal
morbidity.

Public health relevance
PROJECT NARRATIVE Maternal complications associated with oxytocin infusion, such as emergency cesarean section and post- partum hemorrhage, are exacerbated by challenges in achieving optimal dosing due to its wide therapeutic window. This study aims to improve our understanding of the post-translational modifications that influence oxytocin receptor trafficking and degradation. This project may lead to better understanding of oxytocin receptor function and decrease obstetric complications resulting from abnormal uterine contractility.